Therapeutic agents to prevent developmental neuroimpairment after placental hormone loss

PROJECT SUMMARY/ABSTRACT
Premature birth results in early loss of the key endocrine organ of pregnancy, the placenta. Placental endocrine
dysfunction or loss may place many thousands of infants at risk of life-long neurodevelopmental impairment each
year. We have begun to define the placental hormone contribution to neurodevelopmental disorders, such as
autism spectrum disorders (ASD) in a novel mouse model. Reducing a single placental hormone,
allopregnanolone (ALLO), in late gestation produces specific long-term neurodevelopmental deficits that mimic
those seen in preterm birth and ASD. ALLO is a neuroactive steroid synthesized from progesterone by the
placenta during late gestation. It acts on the brain through allosteric activation of GABA-A receptor (GABAAR);
its loss can alter the GABAergic milieu that is critical for normal development. Decreased placental ALLO leads
to alterations in postnatal cerebellar myelination and ASD-like behaviors in a sex-linked manner, with males
showing increased myelination, females a decrease and only males exhibiting ASD-like features including social
cognition deficits and increased repetitive behavior. Both our mouse model and human preterm male cerebellum
showed increased Myelin Basic Protein (MBP) and other protein markers of myelination that, in mice, correlated
with ASD-like behavior. A single ALLO dose injected into pregnant Cre-Lox dams in late gestation rescued the
cerebellar MBP abnormalities and ASD-like behaviors in male plKO mice. These findings support our overall
hypothesis that altered cerebellar white matter development and ASD-like behaviors seen in male offspring
exposed to reduced placental ALLO is amenable to pharmacological treatment. These initial rescue experiments
are promising and we have found a rescue paradigm that works, but there are still critical knowledge gaps that
must be addressed. Here we will test ALLO and two of its engineered derivatives—ganaxolone (GAN), which
has a longer half-life, and gaboxadol (GAB), which activates primarily extrasynaptic rather than synaptic
GABAARs-- all of which have shown good human safety profiles in phase II/III trials for other indications. We will
compare the ability of exogenous ALLO versus its analogues to rescue the complex neurobehavioral effects of
placental hormone loss (Aim 1) and determine the effects of perinatal timing of administration of ALLO or one of
its derivatives (Aim 2) on degree of neurological rescue after placental hormone loss. These agents will be
assessed in our new mouse model using cerebellar MBP expression as an initial biomarker and neurobehavioral
normalization as the relevant therapeutic goal. Accomplishing these aims will provide new mechanistic insights
into the necessary properties of GABAergic agents that best rescue loss of a key placental hormone and take a
practical step towards development of new treatments to prevent or repair the complex neurodevelopmental
sequelae of placental loss.

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH RELEVANCE Understanding the role of placental function in brain development, a new area of investigation that we call neuroplacentology, can provide novel treatments for preterm infants and others at high risk of developmental brain damage. Placental endocrine dysfunction, seen in at least 2% of term pregnancies, or complete, acute loss of placental hormones as occurs with preterm deliveries, representing more than 10% of US births, places these newborns at increased risk for poor neurodevelopmental outcomes, including autism and other life-long impairments. Using our well- defined model of loss of placental allopregnanolone—a potent neuroactive steroid made by the placenta— that results in sex-linked cerebellar white matter and behavioral changes, the proposed experiments will advance our understanding of how this hormone or related compounds could be used to prevent or ameliorate long-term developmental impairments when placental hormones are altered or lost.